Investigating CovRS activation within skin microenvironments to drive heterogenicity of Streptococcus pyogenes gene expression

ABSTRACT
Streptococcus pyogenes infections are a major burden to the healthcare system in the United States and
globally. Most infections are mild and superficial, such as pharyngitis and impetigo. However, rapid disease
progression may result in life-threatening invasive infections, such as necrotizing fasciitis and toxic shock
syndrome. Furthermore, recovered patients often suffer post-infection chronic complications, including acute
rheumatic heart disease. Altogether, S. pyogenes infections and post-infection complications result in more than
600,000 global deaths annually. Currently, there is no vaccine against S. pyogenes and high instances of
morbidity and mortality highlight the urgent need for alternative treatment strategies. Unlike most pathogens, S.
pyogenes thrives in inflammatory environments by expressing virulence factors that promote immune evasion,
which is often associated with invasive infections. Approximately 15% of the genome, including most virulence
factors, is regulated by a two-component system called CovRS (or CsrRS). CovRS detects the host peptide LL-
37, which functions as a potent signal for virulence factor regulation. However, it remains unclear how changes
in LL-37 availability due to cell death alters CovRS regulation during the progression of an infection. Further,
distinct toxins of S. pyogenes are expressed in CovRS “on/off” activity states, yet all are essential during infection.
This indicates that sub-populations of genetically identical bacteria in different CovRS “on/off” states may release
varying toxins during different stages of infection and within distinct microenvironments that collectively
contribute to pathogenesis. I hypothesize that heterogenous CovRS regulation is controlled by variations of LL-
37 levels due to inflammatory cell death, allowing heterogenous toxin production necessary for S. pyogenes
infections. I will test my hypothesis by 1) using genetics techniques within the host and pathogen to identify how
inflammatory cell death impacts LL-37 release and CovRS regulons, and 2) using microscopy for single cell
analysis to examine how local LL-37 concentration contributes to CovRS signaling in engineered S. pyogenes
reporter strains. Collectively, these studies will provide insight into the mechanisms responsible for S. pyogenes-
induced inflammation and identify novel drug targets that stall disease progression.

Public health relevance
NARRATIVE Inflammation induced by the bacteria Streptococcus pyogenes is responsible for rapid disease progression, including necrotizing fasciitis and toxic shock syndrome, resulting in morbidity and mortality during invasive infections. My research will investigate host-pathogen interactions to understand how host inflammatory cell death increases S. pyogenes virulence at a genetic level. Understanding mechanisms that drive inflammation will help identify critical targets to correct protective immunity and stall disease progression.